The effect of muscle-specific anchoring protein on the biology of the Neuromuscular system

Stable and efficient synaptic transmission depends largely on the maintenance of a high
number/density of postsynaptic receptors at synaptic sites. At the neuromuscular junction
(NMJ), the synapse between spinal motor neurons and skeletal muscle cells, the mechanisms
that regulate the stability of postsynaptic nicotinic acetylcholine receptors (AChRs) over the
lifetime of animals remain largely unknown. Recent studies from our lab showed that αkap, a
non-kinase muscle anchoring protein encoded within the calcium/calmodulin kinase II α gene,
plays an important role in regulating the stability of nicotinic acetylcholine receptors (AChRs)
and the structural integrity of the NMJ. In view of these results, we propose in the first aim to
investigate the effect of αkap knockdown during the development of healthy neuromuscular
synapses. In the second aim we propose to investigate the effect of the gain of function of αkap
on the maturation and maintenance of compromised NMJs using mice deficient in the sub-
complex of the dystrophin glycoprotein complex (DGC) (α-syntrophin and α-dystrobrevin). In the
third aim we propose to investigate the molecular mechanistic link between the DGC sub-
complex/αkap/ the deubiquitinating protease USP9X and the stability of AChR stability in mice
deficient in α-syntrophin/α-dystrobrevin, and USP9X. The outcomes of these studies will be
relevant for many neuromuscular diseases where the number and density of AChRs are
compromised.

Public health relevance
The efficiency of synaptic transmission relies on the maintenance of a high number of receptors at the postsynaptic membrane. This proposal will explore the role of muscle calmodulin kinase II-related anchoring protein (αkap) on synaptic development and AChR stability of healthy and compromised neuromuscular synapses. These studies will have a significant impact in understanding the basic mechanisms that underlie the stability of receptors and will be relevant to developing new approaches for treating neurological diseases where the number/density of receptors is compromised.